Cellular Mechanisms of Hypothalamic Inflammation in High Fat Diet-Induced Obesity

DESCRIPTION (provided by applicant): This proposal delineates a 5-year program to provide the training toward the development of an independent academic research career in the study of neuroimmune interactions that affect energy balance. The goal of this research program will be to determine brain mechanisms that govern dysregulation of energy balance in high-fat diet induced obesity in order to provide molecular targets for therapy. The candidate has been prepared for this pathway by completing MD and PhD degrees and clinical training in Internal Medicine and Endocrinology. This research will be conducted in the laboratory of Dr. Michael Schwartz, an expert in the field of hypothalamic regulation of energy balance and glucose homeostasis, and will involve collaboration with a large group of experts in metabolism and inflammatory biology at the University of Washington. It will be overseen by an expert mentoring committee with several members of the Endocrinology Division as well as three external advisors. The clinical problem of weight gain associated with dietary excess has been hampered by a limited understanding of the central nervous system (CNS) mechanisms that account for this disruption in energy homeostasis. Our preliminary data has uncovered a potential interaction between microglia, the immune cells of the brain, and neurons, the regulators of energy balance. At the onset of high-fat feeding, there is a period of early hyperphagia and a concomitant inflammatory response specifically in the hypothalamus. At the same time, an increase in microglial number and cell size occurs in the arcuate nucleus, a region of the hypothalamus containing leptin-responsive melanocortin (POMC) neurons. Blocking microglial activation results in enhanced susceptibility to high-fat diet-induced weight gain. This research will characterize the mechanisms by which high-fat diet-induced inflammation in the hypothalamus contributes to excess weight gain through two specific aims. In Aim 1, we will examine the energy balance, inflammatory, hormonal, and cellular mechanisms by which microglial inhibition confers increased susceptibility to weight gain on high-fat diets. Aim 2 focuses on the effect of preventing high-fat diet-induced inflammation in the POMC neuron on leptin sensitivity, energy balance, and glucose homeostasis. This research course will provide the training and expertise necessary for an independent investigative career while transitioning the PI toward translational research in the expanding field of neuroimmunology. The overarching goal of this proposal is to determine the mechanisms by which inflammatory signals alter energy homeostasis in order to generate better therapeutic options to improve patient care.

Public health relevance
PUBLIC HEALTH RELEVANCE: Obesity is the underlying cause of most cases of type 2 diabetes worldwide. Therapies that target obesity could reduce the incidence of diabetes, thereby greatly improving general health. This research focuses on the brain's role in high-fat diet-induced weight gain with an effort to develop therapies to reduce weight gain. Obesity is the underlying cause of most cases of type 2 diabetes worldwide. Therapies that target obesity could reduce the incidence of diabetes, thereby greatly improving general health. This research focuses on the brain's role in high-fat diet-induced weight gain with an effort to develop therapies to reduce weight gain. __SpecificAimsTextDelimiter__ 10. Specific Aims Obesity plays a central role in the pathogenesis of type 2 diabetes; therefore, effective treatment of obesity has unparalleled potential to lower diabetes risk. Unfortunately, our incomplete understanding of obesity pathophysiology has impeded efforts to treat or prevent this disorder. Recently, a series of seminal studies in rodents and humans has highlighted the important role of inflammation in the metabolic dysregulation of obesity (1-5). High-fat diet (HFD)-induced obesity is associated with expansion of the macrophage compartment within adipose and other peripheral tissues, generating an inflammatory milieu that promotes insulin resistance (3-5). A similar response to HF feeding has now been demonstrated in the hypothalamus (6- 10), although the role played by immune cells is unclear. Whereas inflammation in peripheral tissues is a consequence of obesity (11), Nuclear Factor κB (NF-κB) signaling in hypothalamic neurons has the potential to promote weight gain by inducing resistance to the key weight-regulating hormones insulin and leptin. Consistent with a causal role, animals with impaired NF-κB signaling specifically in neurons are less susceptible to diet-induced obesity and its metabolic sequelae (10). Furthermore, our preliminary results implicate microglia, the primary immune cells of the brain, as modulators of hypothalamic inflammatory signaling during HF feeding. This proposal centers on the hypothesis that microglia play a protective role in the response to a HFD by restraining neuronal inflammation and consequent weight gain. Our Preliminary Results show that the onset of HF feeding is accompanied by a nearly immediate rise of both food intake and hypothalamic inflammatory gene expression, and that both parameters return to baseline levels by the end of the first week on the HFD. Concurrently, the number of microglia increases selectively within the arcuate nucleus (ARC)-a hypothalamic region that is critical for energy homeostasis and contains leptin-sensitive proopiomelanocortin (POMC) neurons (12, 13)-consistent with the hypothesis that neuronal inflammation induced by the HFD triggers a microglial response. Most importantly, intracerebroventricular (icv) infusion of either of two relatively selective microglial inhibitors-IL-4 or minocycline-causes excessive weight gain in rats on a HFD. Together these data suggest that hypothalamic neurons respond to HFD by producing inflammatory signals that recruit microglia in a protective role to limit further weight gain. Through investigation of the central hypothesis, we will expand on growing evidence that the interactions between microglia and neurons are critical determinants of both hypothalamic inflammation and obesity pathogenesis during HF feeding. Aim 1: To clarify the microglial contribution to HFD-induced obesity. Our preliminary data demonstrate that icv infusion of either IL-4 or minocycline, relatively specific inhibitors of microglia (14-16), promote HFD-induced obesity. Furthermore, as microglia accumulate in the ARC, food intake returns to normal levels and hypothalamic inflammation resolves. Here we test the hypothesis that microglia restrain neuronal inflammation during HF feeding, thereby limiting weight gain. We will investigate mechanisms by which microglial inhibition promotes HFD-induced obesity using pharmacological (central minocycline infusion) and genetic (microglial-specific NF-κB pathway knockout mice (17)) approaches. 1. Energy balance: With indirect calorimetry and metabolic monitoring using established methods, we will resolve whether food intake is increased, energy expenditure reduced, or both. 2. Inflammation: Using flow cytometry and immunomagnetic cell separation, methods recently established in the lab by the applicant, we will assay the inflammatory response in neurons and microglia. 3. Hormonal mechanism: We will determine whether increased hypothalamic leptin resistance is responsible for the excess weight gain using established behavioral and biochemical methods. 4. Cellular mechanism: We will use immunohistochemistry to determine whether reduced microglial accumulation in the ARC is linked to excess weight gain during HF feeding. Aim 2: To determine whether POMC neuron inflammation promotes HFD-induced weight gain. Reduced melanocortin signaling causes obesity whether induced genetically, pharmacologically, or as a result of HFD-induced leptin resistance (18-20). Conversely, interventions that prevent leptin resistance in these cells protect against HFD-induced weight gain and peripheral tissue insulin resistance (21, 22). We will test the hypothesis that reducing inflammation selectively in POMC neurons alleviates HFD-induced leptin resistance, thereby limiting weight gain and peripheral insulin resistance, by studying energy regulation and glucose homeostasis in POMC neuron-specific NF-κB pathway knockout mice. All of the animals, methods, and resources needed to perform these studies are currently available to the applicant. Although pursuit of a novel, emergent area of research entails an inherent degree of risk, I feel confident that this endeavor will provide a valuable training experience regardless of the outcome of the experiments proposed herein. First, it is now established that hypothalamic inflammation occurs in common forms of obesity and is implicated in the pathogenesis of weight gain during HF feeding. Therefore, studies aimed at understanding the causes and consequences of hypothalamic inflammation in the context of HFD-induced obesity are likely to open fruitful avenues of investigation for years to come. Further, based on my preliminary functional data and the support of a growing body of published evidence (6-10), I believe that a significant role for microglia and inflammation in POMC neurons in obesity pathogenesis is a feasible and testable hypothesis that is of compelling interest. Thus, a clear rationale exists for the mechanistic studies I propose, studies that lay the groundwork for the future development of therapeutic interventions. Lastly, the acquisition of new knowledge and techniques in the field of neuroimmunology, the interaction with a diverse group of successful academicians on the mentoring committee, and the unique opportunity to explore a novel hypothesis under the protective tutelage of an experienced, established senior scientist will ensure that this career development phase will reward me with the skills and training to become a successful independent investigator.